Neurocognitive outcomes and changes in brain and CSF volume after treatment of post-infectious hydrocephalus in Ugandan infants by shunting or ETV/CPC: a randomized prospective trial

The goals of this R01 Renewal are driven by the results of our successfully conducted randomized
controlled clinical trial comparing endoscopic third ventriculostomy combined with choroid plexus
cauterization (ETV/CPC) to shunt treatment for post-infectious hydrocephalus (PIH, the most common
hydrocephalus etiology in Uganda) in infants < 6 months of age (ClinicalTrials.gov NCT01936272,
R01HD085853, R21HD068213) at the CURE Children’s Hospital of Uganda (CCHU). The interim
outcomes of this study are becoming a landmark in children’s medicine, finding that: a) at up to 24
months, there was no significant difference between ETV/CPC and shunt in regard to failure rate,
developmental outcome, and brain growth; b) brain volume, not CSF volume, correlated strongly with
developmental outcome; c) successful treatment of the hydrocephalus led to improved brain growth in
the first year, which stagnated during the second year. Because almost all of the failures of endoscopic
treatment occurred early in the first year of life, we anticipate that the longer term outcomes of
hydrocephalus treatment may favor endoscopy if we follow these children through primary school age
from 5 to 10 years. Furthermore, our ability to perform much more detailed neurocognitive assessments
during this further followup will be much more accurate than during our pre-school assessments. Lastly,
we can gather all of our data and perform a much more definitive cost-effectiveness analysis if we can
follow this unique cohort for a full 10 years.
We have engaged in substantial capacity building during the previous 5 years of support during this
clinical trial. We have developed a thriving research unit at the CURE Children’s Hospital of Uganda,
enabling high-quality research to be conducted in multiple other NIH funded studies unrelated to this
clinical trial (DP1HD086071, R01AI145057, and R01HD096693). Furthermore, since all hydrocephalus
treatment requires brain imaging, we have developed a thriving center for sustainable low-field MRI
engineering at the Mbarara University of Science and Technology.
This present project seeks to follow this unique cohort to 10 years of age, seeking to definitively
establish whether endoscopic treatment is more sustainable for infants in the developing world, establish
low field MRI as a sustainable imaging technology, and establish the capacity of both the medical and
engineering sites in Uganda as independent research and technology development centers for Africa.

Public health relevance
Project Narrative This is a unique randomized clinical trial in Africa comparing the two best surgical options - shunt versus endoscopic - for treating post-infectious hydrocephalus, the dominant cause in African infants. Our 1-year results demonstrated that there was no disadvantage to using the more sustainable endoscopic approach over the older standard of shunt insertion, made the surprising discovery of brain growth arrest before and brain growth catch-up after treatment, and the further discovery of brain growth stagnation during the second year of follow up despite adequate control of intracranial pressure. This present project seeks to follow this unique cohort to 10 years of age, to definitively establish whether endoscopic treatment is more sustainable for infants in the developing world, establish low field MRI as a sustainable imaging technology, and establish the capacity of both the medical and engineering sites in Uganda as research and development centers for Africa.